Endocrine disrupting chemical mixtures and bone health in adolescence

Abstract
Low bone mineral density (BMD) during adolescence is associated with fractures in adolescence and
adulthood as well as increased risk of osteoporosis, a chronic bone disease affecting more than 10 million
older adults in the U.S. The majority of Americans are exposed to perfluoroalkyl substances, phthalates, and
organophosphate esters, synthetic endocrine disrupting chemicals (EDCs) that have adverse skeletal effects in
laboratory studies. In humans, these EDCs are associated with lower BMD in limited cross-sectional studies
and prospectively associated with lower BMD at age 12 years in our preliminary data. However, few studies
have assessed relationships of EDCs with bone health in adolescence, a period of rapid bone mineralization
that may be highly sensitive to environmental exposures and is strongly predictive of adult BMD. Therefore, the
overarching objective of our proposal is to determine whether exposure to individual EDCs or their mixtures
causes reduced bone accrual and strength in adolescence. We will address our aims within the Health
Outcomes and Measures of the Environment (HOME) Study, a prospective birth cohort study of mothers and
their children enrolled in Cincinnati, Ohio. The HOME Study has amassed detailed longitudinal exposure
biomarker measures and covariate data on participants from gestation through 12 years of age. We will
conduct a new follow-up visit of 225 participants at approximately 17 years of age to measure EDC
biomarkers; perform detailed skeletal assessments; and collect information on diet, physical activity,
anthropometry, and pubertal status. Using these data, we will determine whether EDC exposures are
associated with peripheral quantitative computed tomography measures of volumetric BMD, bone geometry,
and strength strain index at age 17 years (Aim 1); dual-energy X-ray absorptiometry measures of areal BMD at
age 17 years and rate of aBMD accrual from age 12 to 17 years (Aim 2); and fracture history at age 17 years
(Aim 3). We will elucidate the impact of lifetime cumulative EDC exposures and identify periods of heightened
susceptibility by applying sophisticated statistical approaches including Bayesian and lagged kernel machine
regression and latent profile analysis. This work will inform the development of targeted interventions for
optimizing bone health in adolescence with the long-term goal of reducing risk of fractures and osteoporosis
throughout life.

Public health relevance
Achieving optimal bone accrual and strength in adolescence reduces risk of fractures and osteoporosis throughout life. Bone health may be affected by exposure to endocrine disrupting chemicals commonly found in consumer products. We will investigate the impact of these chemicals on bone strength and fractures in adolescence with the aim of identifying new ways to optimize lifelong bone health.